Corticofugal contributions to auditory perceptual learning

PROJECT SUMMARY
Practice can improve the detection or discrimination of auditory stimuli. This process, called perceptual
learning, facilitates language acquisition and the development of musical skills, and improves speech
understanding in the hearing-impaired. Previous studies have highlighted the importance of the auditory cortex
in auditory perceptual learning, but we lack a complete understanding of the neural circuit mechanisms involved.
Corticofugal projections from the auditory cortex to subcortical auditory regions comprise a massive descending
pathway. This pathway integrates non-sensory inputs, which are essential to perceptual learning, with sensory
information and sharpens neural responses to relevant stimuli in subcortical auditory regions. Inactivation of this
corticofugal pathway also impairs learning in sensory tasks with difficult, near-threshold stimuli. Taken together,
the existing evidence suggests that corticofugal projections are well-positioned to play an important role in
perceptual learning. The core hypothesis of this proposal is that perceptual training strengthens
corticofugal modulation of activity in the ascending auditory pathway, leading to gradual enhancements
in signal detection that underlie perceptual learning. Aim 1 will use in vivo electrophysiology in freely-moving,
behaving animals to determine whether there are learning-related changes in neural activity in subcortical
auditory regions. Aim 2 will investigate whether corticofugal projections are necessary for the acquisition and/or
maintenance of training-induced improvements in perceptual sensitivity. Aim 3 will use projection-specific fiber
photometry recordings to assess if the activity of corticofugal neurons correlates with behavioral improvements
during perceptual learning. The findings from the proposed experiments will shed light on the neural circuits
underlying auditory perceptual learning and may ultimately inform strategies to improve auditory perception in
clinical populations.

Public health relevance
PROJECT NARRATIVE Auditory perceptual learning shapes many important components of aural communication, such as speech production and phoneme discrimination, and can improve the recognition of ambiguous or degraded speech in patients with hearing loss. While the auditory cortex plays a critical role in perceptual learning, the cell types and circuits involved are only beginning to be understood. The proposed experiments will address this issue by exploring the contribution of one specific cell population, layer 5 auditory corticofugal neurons, to auditory perceptual learning.